Integrative genomic and functional genomic studies to connect variant to function for CAD GWAS loci

PROJECT SUMMARY
Atherosclerotic coronary artery disease (CAD) remains the leading cause of death globally, despite effective
therapies for many known risk factors. The majority of CAD loci identified by genome-wide association studies
(GWAS) are not associated with traditional risk factors, providing opportunities to discover novel mechanisms
and therapies. Encouragingly, many new therapies targeting causal genes and pathways inspired by GWASs
have received approval or fared favorably in clinical trials. Despite the success, the bottleneck remains the lack
of experimental studies systematically linking CAD variants to the causal genes and pathways at scale in a cell
type-specific manner. To overcome these barriers and define tissue/cell type-specific contribution to the genetic
predisposition of CAD risks, we leverage the STARNET eQTL data in nine CAD-relevant tissue/cell type
from >1300 subjects and public eQTL data of immune and vascular cells. Aim 1 will apply advanced
computational pipelines to nominate candidate causal CAD variants, cis-regulatory elements (cREs), and their
target genes and related pathways at CAD loci in CAD-relevant tissue and cell types, providing tissue/cell type-
specific mechanistic and therapeutic insights for CAD. Initial analysis supports that ~30% CAD risk loci are most
strongly associated with eQTLs in macrophages or foamy macrophages compared with the other seven tissues
in STARNET data. This is in line with the major role of circulating monocyte-derived macrophages in driving
atherosclerosis. Leveraging the rich functional genomic datasets available for monocytes/macrophages, Aim 2
will apply mid-throughput functional assays, including single-cell CRISPR screening, massively parallel reporter
assay, and arrayed knockout or overexpression cellular assays, to experimentally define the genetic
contributions of monocytes/macrophages to CAD by connecting variants to genes and phenotypic roles, and
build machine learning models predicting functional cREs and their target genes. Our study addresses unmet
needs in the functional follow-up of CAD GWASs by performing integrative genomic analysis of CAD loci at an
unprecedented scale, experimentally connecting variant to function in cell types critical for the genetic
predisposition of CAD, building machine learning models for predicting functional cREs and their target genes
for improved prioritization workflow, and providing a generalizable framework for extended discoveries in other
CAD-relevant cell types. With the MPI’s expertise in statistical genetics, machine learning, macrophage biology,
and functional genomics, our study has significant and broad impacts by providing (1) novel insights into
tissue/cell type-specific contributions to the genetic predisposition of CAD that inform new biological mechanisms
and therapeutic targets; (2) a catalog of phenotypically tested target genes highly likely to be causal for CAD,
allowing immediate refocus to the most promising targets for accelerated translation, and (3) an innovative
computational and experimental framework for systematic variant-to-function discoveries.

Public health relevance
PROJECT NARRATIVE Genome-wide association studies have identified over 200 independent loci that influence coronary artery disease (CAD) risk, yet determining the causal genes connecting genetic variation to disease susceptibility has lagged. Leveraging computational pipelines and machine learning models using large-scale functional genomic datasets, and scalable functional genomic screens with targeted validation, our study systematically identifies the functional regulatory elements that contain the risk variants and regulate the expression of target genes and phenotypic outcomes at CAD loci. Our results provide (1) novel insights into tissue/cell type-specific contributions to the genetic basis of CAD, and (2) an innovative computational and experimental framework for systematic variant-to-function discoveries.